Texas A&M Center for Environmental Health Research (TiCER)

ABSTRACT Pilot Project
The Texas A&M Center for Translational Environmental Health Research (TiCER) is a major hub for the
development and growth of health research on campus through attracting faculty from multiple schools, colleges,
and departments. In addition, TiCER scientists play leading roles in ongoing environmental health programs
including the P42 Superfund Basic Research Program, the T32 Toxicology Training Grant in Regulatory
Sciences, and the Interdisciplinary Faculty of Toxicology (IFT). TiCER and earlier funded P30 grants at Texas
A&M University focused on impacting underserved rural areas, a focus that will be continued and expanded in
the renewal grant application. The Pilot Project Program (PPP) plays a key role in many aspects of the center
by stimulating research in areas consistent with center goals and by funding novel studies conducted by faculty
not previously committed to environmental health research. This approach is critical to the expansion of the
center and development of new thematic areas of research including “Climate Change and Health,” which grew
out of PPP funding. Thus, the PPP is a critical element in both the ongoing and future health research activities
of the center as is evidenced by the large number of applicants for PPP funding from multiple academic units. In
order to maintain and improve the PPP, four major Aims will be pursued: 1) Maintaining a well-organized Pilot
Project structure that will announce, disseminate, receive review, and fund individual and collaborative projects
in a timely fashion as outlined in the grant application; 2) Attract junior faculty and investigators new to
environmental health research in order to expand this field and develop new collaborations and themes; 3)
Enchance collaborative research not only in “individual” Pilot Projects but also through “collaborative grant”
competitions; 4) Encourage inter-Center collaborations that will involve faculty from more than one center as this
will further enhance the overall impact of proposed collaborative research.